EFFECT OF DIET, EXERCISE &COMBINATION IN TREATMENT OF OBESE TYPE II DIABETES

The specific aims of the study are to recruit 200 obese individuals with type II diabetes and 200 obese individuals who have a positive family history of diabetes. These subjects will be randomly assigned to usual care or to behavioral weight control programs which include either structured diet, structured exercise or the combination. All subjects will be assessed at baseline, 6 months, 1 year and 2 years on measures of weight, glycemic control, coronary heart disease (CHD) risk factors, and eating and exercise behaviors.